Physiologically based Pharmacokinetic modeling

The purpose of this contract is to provide support for the development of physiologically based pharmacokinetic models for environmental chemicals. These models will be used in study design, interpretation of toxicological data and extrapolating the animal data to humans.